Liquid Helium Recovery System to Improve Shared Chemistry Instrumentation Core

The University of Hawaii at Hilo (UH Hilo) is an Institution of Emerging Excellence in pharmaceutical and
environmental health sciences with a Shared Chemistry Instrument (SCI) core that supports biomedical
research conducted by a diverse team of investigators across campus with expertise in medicinal, natural
products, organic, environmental, photo, and pharmaceutical chemistry. Given that the NMR instruments are
critical to the productivity of these researchers and that helium is a non-renewable resource with steadily
increasing costs, the addition of an advanced liquid helium recovery and liquefaction system will enable major
improvements in operational efficiencies, strategically promote using shared resources, and strengthen our
active biomedical research at the college of pharmacy and across UH Hilo. The long-term objective of this
proposal is to enhance the sustainability and impact of the SCI core. This modernization project will advance
research-related activities of the SCI core to support biomedical research and enhance the efficacy of the
core’s operation through achievement of two aims: Aim 1. Reduce SCI core operating costs through the
purchase and installation of a modern helium recovery system. Aim 2. Expand access to the core by
offering lower NMR user fees and helium liquefaction services.

Public health relevance
The Shared Chemistry Instrument (SCI) core at the University of Hawaii at Hilo supports biomedical research conducted by a diverse team of investigators across campus with expertise in medicinal, natural products, organic, environmental, photo, and pharmaceutical chemistry. Given that the NMR instruments are critical to the productivity of these researchers and that helium is a non-renewable resource with steadily increasing costs, the addition of an advanced liquid helium recovery and liquefaction system will enhance the sustainability and impact of the SCI core. This modernization project will reduce SCI core operating costs through the purchase and installation of a modern helium recovery system and will expand access to the core by offering lower NMR user fees and helium liquefaction services.